CORE--ADULT CLINICAL CORE FACILITY

The Adult Clinical Core at the Beth Israel Hospital will serve to provide clinical specimen to the Dana-Farber Cancer Institute CFAR investigators, facilitate trials of therapies evolving from the basic research of CFAR members and encourage scientific exchange and collaborations between clinical and basic science investigators. The Beth Israel Hospital provides primary care to approximately 480 HIV-infected adults and has extensive NIH funded clinical research programs at the hospital, including a component of the Harvard/Boston City Hospital Aids Clinical Trials Unit (ACTU). The Adult Clinical Core will provide partial support for both a research nurse and a laboratory technician. The research nurse will provide CFAR investigators with clinical specimens from patients and carefully document the clinical histories of these patients for the investigators. The laboratory technician will establish and characterize HIV isolates from patients and maintain a bank of clinical specimens for the use of CFAR investigators. Both the research nurse and laboratory technician will also participate in the trials of therapies initiated through the Dana-Farber Cancer Institute-Beth Israel Hospital interactions. CFAR Cores will be made available to AIDS clinical investigators at the Beth Israel Hospital to strengthen the scientific base of their clinical studies. Finally, joint institutional conferences will be held to foster scientific collaborations and encourage the initiation of clinical trials of novel AIDS therapeutics.